PULSATILE ADMINISTRATION OF GNRH FOR INDUCTION OF OVULATION--AMENORRHEA

To determine the safety and efficacy of GnRH for the induction of ovulation in amenorrhea women, we will administer this releasing hormone by pump every 90 mon. as 20 ug/pulse SC or 5 ug/pulse IV.